The role of TMTC4, endoplasmic reticulum Ca2+ flux, and the unfolded protein response in noise-induced hearing loss

PROJECT SUMMARY
Noise-induced hearing loss (NIHL) is a significant public health problem, affecting nearly 40 million Americans.
We have made the exciting discovery that NIHL may be linked to the unfolded protein response (UPR), a critical
early response mechanism to cellular stress that has downstream effectors that can promote both cell survival
and apoptosis. In support of this, we have additionally identified and characterized a novel deafness gene in
mice, Tmtc4, which has also been recently identified as a potential deafness gene in a human family. Mice in
which Tmtc4 is genetically absent (Tmtc4 knockout (KO) mice) hear normally at the onset of hearing but rapidly
become deaf within 2 weeks and have markedly increased susceptibility to NIHL. We have found that Tmtc4 is
broadly expressed in cochlear hair cells and supporting cells, both of which degenerate over time in Tmtc4 KO
mice. We have shown that Tmtc4 is part of a macromolecular complex involved in clearing calcium (Ca2+) from
the cytoplasm into the endoplasmic reticulum (ER), and that cochlear cells from Tmtc4 KO mice have
impairments in intracellular Ca2+ homeostasis and dynamics. This impairment in Ca2+ management leads to
upregulation of the UPR and cell death in the Tmtc4 KO cochlea. In parallel with this genetic deafness model of
UPR dysregulation, we have found that NIHL in wild-type (WT) mice results in UPR upregulation within 2 hours
of noise exposure; this hearing loss could be prevented in part by treatment with one drug, ISRIB, that specifically
targets the UPR, or a second drug, CDN1163, that facilitates Ca2+ reuptake into the ER. These preliminary
findings strongly implicate the UPR as an early mediator of cellular stress in the cochlea, upstream of other
previously studied apoptotic mechanisms, and thus is a potential therapeutic target for a wide range of acquired
and genetic forms of hearing loss.
In this proposal, our specific aims are to investigate 1) how, in cell lines, TMTC4 dysfunction, including
human variants associated with hearing loss, affect ER Ca2+ flux and, subsequently, UPR activation; 2) how, in
the cochlea, noise-induced trauma in the form of hair-cell tip-link disruption and ER Ca2+ depletion activate the
UPR to induce hair-cell loss; and 3) how, in in vivo models of hearing loss, the UPR is modulated to give rise to
different patterns of hearing loss and hair-cell death. These Aims will be achieved using a multidisciplinary set
of physiologic, biochemical, pharmacologic, and genetic techniques including ER Ca2+ imaging, mRNA
transcriptional analysis, and genetic TMTC4 conditional knockout mice. Through these experiments, we will gain
valuable insight into the mechanisms by which ER Ca2+ flux and the UPR are involved in genetic and noise-
induced hearing loss, laying the foundation for development of targeted therapies for NIHL, a critical unmet
clinical need.

Public health relevance
PROJECT NARRATIVE Noise-induced hearing loss affects nearly 40 million Americans. We have newly identified a pathway critically involved in the ear's early response to loud sound. In this grant, we aim to learn more about how this pathway is involved in hearing and deafness, so that we may develop drugs to target this pathway and prevent hearing loss.